Endoplasmic Reticulum (ER)-phagy in Influenza Infection

Project Summary
Influenza infection in susceptible patients results in a higher viral load, cytokine storm, tissue
damage, lung function decline, and mortality. It is well known that interferons control influenza
burden and inflammatory responses. However, mechanistic understandings of IFN-mediated
regulation of influenza burden in the lung epithelial cells is unclear. We have identified a novel
association between Endoplasmic Reticulum (ER)-specific-autophagy response, termed ER-
phagy, as regulators of the influenza burden in lung epithelial cells. Characterizing the epithelial
ER-Phagy-IFN axis in influenza infection will be the focus of the current application. Unraveling
this axis in lung epithelial cells provides much-needed mechanistic insights into controlling viral
burden and mitigating virus-induced lung injury. Our preliminary data suggest that levels of ER-
phagy receptors in lung epithelial cells regulate viral burden in an IFNβ dependent manner.
Based on these novel data, we hypothesize that lung epithelial cells upregulate IFNβ- and IRE1-
dependent ER-phagy to diminish viral burden. We will test this hypothesis in the following
specific aims: In specific aim 1, we will determine that specific ER-phagy receptors are required
to decrease influenza burden in epithelial cells and subsequent lung injury. Aim 2 will use
epithelial-specific knockouts of IFNAR1 receptor and recombinant interferons to determine that
the type-I IFNs regulate ER-phagy activity post-IAV infection to control IAV burden and lung
injury. These studies will determine that the ER-Phagy-IFN axis acts as a first line of defense in
the primary site of influenza infection (epithelial cells) to decrease the IAV burden and
subsequent lung injury.

Public health relevance
Project Narrative How lung cells handle flu burden and whether innate lung cell processes affect influenza load is unclear. This proposal explores the role of specialized cellular material engulfing process called “ER-phagy” in flu clearance and lung damage mitigation.